PPAR gamma as a therapeutic target in COPD

DESCRIPTION (provided by applicant): An improved understanding of the mechanisms leading to COPD pathogenesis, as well as novel targets for therapeutic intervention, are needed. Peroxisome proliferator-activating receptor (PPAR)-γ has been previously shown to be capable of regulating inflammatory responses in multiple organs. PPARγ-activating ligands, the thaizoladinediones (TZDs), are FDA approved. Regulation of PPARγ activity, using these drugs, is associated with reduced morbidity in animal models of inflammatory lung disease. However, the importance of this molecule in lung epithelial cells and in COPD has not been determined. We find increased expression of PPARγ in human COPD tissues, and in epithelial cells from smokers. In lung epithelial cells, PPARγ can regulate genes associated with lung tissue remodeling. We have previously reported that deficiency in PPARγ specifically within epithelial cells leads to a defect in lung maturation resulting in variation in lung structure and function in mice. Here, we present data indicating that mice deficient in lung epithelial cell PPARγ also show increased susceptibility to the development of emphysema in response to chronic cigarette smoke exposure. This is associated with an increase in the accumulation of inflammatory macrophages, the critical effector cell for emphysema pathogenesis, and increased lung chemokine gene expression. We present preliminary data indicating that activating PPARγ using TZDs in mice reduces smoke-related inflammation and chemokine expression, critical cellular and molecular intermediate phenotypes in this pre-clinical model of COPD. In vivo, epithelial cells are highly responsive to PPARγ regulators, and exposure to cigarette smoke increased PPARγ expression, supporting the contributions of epithelial cell PPARγ in regulating smoke-induced inflammation. In total, these data support a role for PPARγ as a susceptibility factor in COPD with potential as a target for disease-modifying therapy. We hypothesize that reduced PPARγ activity increases susceptibility to smoke- induced lung injury and that exogenous activation of PPARγ using TZDs will reduce COPD morbidity. We propose that epithelial PPARγ functions specifically to regulate the expression of epithelial-derived chemokines involved in inflammatory cell recruitment, macrophage activation and tissue destruction in response to chronic smoke exposure. In an effort to test these hypotheses we propose to: 1) Define the cellular and molecular mechanisms leading to increased susceptibility to cigarette smoke-induced emphysema in the absence of lung epithelial cell PPARγ function in mice. 2) Evaluate PPARγ-activating therapeutic ligands for the ability to limit emphysema pathology in mice exposed to cigarette smoke. 3) Investigate the ability of PPARγ activation to suppress smoke-induced lung epithelial cell chemokine expression in human cells and in COPD subjects as part of a phase II clinical trial. In total, these experiments will test the mechanistic role of PPARγ in a preclinical model of COPD, specifically address the role of epithelial cell PPARγ in regulating disease pathogenesis, and evaluate relevance and potential therapeutic benefits of PPARγ activation in humans with COPD. PUBLIC HEALTH RELEVANCE: Chronic Obstructive Pulmonary Disease (COPD) represents the fourth leading cause of death in the United States. The need for identification of novel therapeutic targets for this debilitating disease has recently gained heightened interest. The studies described in this application will test the role of peroxisome proliferator- activated receptor (PPAR)-γ function in COPD using a pre-clinical mouse model of disease, and test the ability of FDA-approved, PPARγ-targeted drugs to affect disease-related phenotypes in human COPD subjects.

Public health relevance
Chronic Obstructive Pulmonary Disease (COPD) represents the fourth leading cause of death in the United States. The need for identification of novel therapeutic targets for this debilitating disease has recently gained heightened interest. The studies described in this application will test the role of peroxisome proliferator- activated receptor (PPAR)-γ function in COPD using a pre-clinical mouse model of disease, and test the ability of FDA-approved, PPARγ-targeted drugs to affect disease-related phenotypes in human COPD subjects.